Addressing Disparities in Pain Management among Veterans: A Decision Tool to Support Preference-Based Safe Prescribing and Treatment Decisions in Primary Care

Background: A common clinical presentation in the primary care setting is of patients with symptoms of acute
pain. The effective, safe, respectful, and equitable evaluation, diagnosis, and treatment of pain symptoms is
essential for patient well-being. However, provider-patient communication about pain treatment decisions is
difficult for many providers, lacks structured information about treatment options, and has led to disparities in
adequate pain management and trust. These factors limit the quality of the treatment decision making process.
Guidelines for safe prescribing practices related to chronic pain have been developed by the Department of
Veterans Affairs and other professional organizations. However, clinicians lack to tools to present patients with
evidence based alternative treatment options. Our group has developed and piloted a Web-Based Pain
Treatment Option Grid (PainRxOptionGrid) that has been studied in an Emergency Department setting. This
tool provides a one screen display of treatment options and evidence-based attributes of each option
(Strength, Risk of Addiction, Side Effects, How they Work, Cost, Time to Return to Work). Clinicians can use
the tool to limit the choice set as needed and indicate their default recommendation or option for each patient.
Patients can then select the attributes that are most important to them and indicate their treatment preference.
Together, these features provide a framework for a patient-provider discussion about value-based treatment
options for pain control. Usability studies in the ED setting found the tool to be easy to use and acceptable to
providers and patients. However, the tool has not been adapted for the Veteran population, for persons of
diverse race and gender, or for use in the primary care setting.
Significance/Impact: Safe, effective, and equitable control of pain is a priority in provision of primary care for
Veterans. A review of HSR&D and ClinicalTrial.gov websites identified no recent or ongoing studies applying
principles of shared decision making or developing patient-provider communication strategies for pain
treatment in primary care. This work will address a gap in our primary care pain management program.
Innovation: The PainRxOptionGrid is innovative in applying principles of SDM and behavioral economics to
support the adoption of evidence based, patient-centered, and value aligned decisions in pain management.
Specific Aims:
Aim 1: To evaluate and adapt the PainRxOptionGrid for use among clinicians and Veterans diverse in race,
age, education and gender and for use in the primary care clinical setting.
Aim 2: To conduct usability testing of the adapted PainRxOptionGrid among Veterans who present to a primary
care clinic with an acute episode of pain defined as having symptoms of pain for less than 4 weeks.
Methodology: In Aim 1, we will conduct structured interviews among 12 to15 clinicians and 22 to 36 Veterans
in the primary care setting to assess a) barriers and facilitators to use, and b) salience and clarity of the content
and format of the PainRxOptionGrid. Findings will inform modification of the tool for this setting and population.
In Aim 2, we will conduct usability testing of the modified tool among 26 to 28 Veterans who present to primary
care with new acute pain. Sampling will ensure that 40% are Black or African American and 25% are female.
Outcomes will include the System Usability Scale, the Decisional Conflict Scale, the Interpersonal Processes
of Care scale, pain treatment choice, pain control at 1 week and 1 month, and data on the time spent using the
tool in the clinic visit. The study will take place at the Crescenzi VA Medical Center in Philadelphia, PA.
Next Steps/ Implementation: This pilot study will provide the data needed to conduct a Hybrid Type 1
Effectiveness-Implementation trial of this intervention. We will work with partners from the Primary Care Pain
Initiatives and the Pain Management, Opioid Safety and Prescription Drug Monitoring Programs to integrate
our findings and plans for further studies into ongoing National VA initiatives in pain management.

Public health relevance
A common clinical presentation in the primary care setting is of patients with symptoms of acute pain. The effective, safe, respectful, and equitable evaluation, diagnosis, and treatment of pain symptoms is essential for patient well-being. However, provider-patient communication about pain treatment decisions is difficult for many providers, lacks structured information about treatment options, and has led to disparities in adequate pain management and trust. We have developed a Web-Based Pain Treatment Option tool that has been studied in an Emergency Department setting. In this study, we will adapt the tool for use among clinicians and Veterans for use in the primary care clinical setting. We will then evaluate the usability of the tool among Veterans who present to a primary care clinic with an acute pain. The study will take place at the Crescenz VA Medical Center in Philadelphia, PA.